1/2 A randomized controlled trial of pravastatin to prevent preeclampsia in high-risk women

ABSTRACT
Preeclampsia complicates approximately 3% to 5% of pregnancies and remains a major cause of maternal and
neonatal morbidity and mortality. Women who have experienced preeclampsia in one pregnancy are at high
risk for preeclampsia in subsequent pregnancies with the magnitude of the risk depending on the severity and
gestational age at delivery in the index pregnancy. Preeclampsia shares pathogenic similarities with adult
cardiovascular diseases as well as many risk factors. Endothelial dysfunction and inflammation are
fundamental for the initiation and progression of both. Prevention of preeclampsia using various supplements
and medications have had limited success. In contrast, there is strong evidence that 3-hydroxy-3-
methylglutaryl-coenzyme A reductase inhibitors (statins) are beneficial in primary and secondary prevention of
cardiovascular mortality and other cardiovascular events. Biological plausibility, animal data, and pilot clinical
trials support a similar role for pravastatin, a hydrophilic statin with a favorable safety profile, in preventing
preeclampsia prevention. In addition, the current evidence from animal studies and human pregnancy
exposure cohorts do not support previous teratogenicity claims of pravastatin. Therefore, we propose a
multicenter, double-blind, placebo-controlled randomized clinical trial to determine whether prophylactic
treatment with pravastatin administered early in pregnancy reduces preeclampsia in high-risk women. A total of
1,760 pregnant women at high risk for preeclampsia (due to history of preeclampsia in a prior pregnancy that
required delivery before 360/7 weeks) will be randomized between 100/7 and 166/7 weeks to pravastatin 10 mg or
similar-appearing placebo, daily at bedtime until delivery. Women and their neonates will be followed
throughout pregnancy and up to 6 weeks post partum to address the primary aim: evaluate whether treatment
with pravastatin reduces the recurrence rate of preeclampsia; as well as the following secondary aims:
(1) evaluate whether pravastatin improves maternal and neonatal outcomes; (2) assess the maternal and
fetal/ neonatal safety profile of pravastatin during pregnancy; and (3) determine whether pravastatin
administration in pregnancy reverses the angiogenic imbalance associated with preeclampsia by reducing the
concentrations of the anti-angiogenic factors soluble Fms-like tyrosine kinase-1 (sFlt-1) and soluble endoglin
(sEng), and increasing that of placental growth factor PlGF (angiogenic).

Public health relevance
PROJECT NARRATIVE Pravastatin has been shown in preclinical and pilot studies to prevent preeclampsia (hypertensive complication in pregnancy) without significant maternal and neonatal complications. The aims of this trial are to determine if pravastatin prevents preeclampsia in high-risk pregnant women, improves pregnancy outcomes, is safe for the mother and fetus, and to determine its possible mechanism of action. This trial seeks to identify an effective treatment in the prevention of this devastating complication of pregnancy.